HRSA/NHDP Support for Leprosy Reagents

This agreement between NIAID and the National Hansen's Disease Program (Health Resources and Services Administration) supports the production of Mycobacterium leprae and M. lepromatosis bacteria and related reagents.